Developmental Core

PROJECT SUMMARY (See instructions): The UCLA CFAR Developmental Core provides seed funding for innovative research projects as well as training for submission and review of NIH- style applications. These grants, which allow investigators to obtain the preliminary data they need to support R01 applications or program projects, are an increasingly important aspect of the UCLA CFAR's overall activities as other sources of potential funding, including federal sources, have reduced their allocations. New and junior investigators, in particular, require support in order to establish a productive scientific career. Collaborative research projects are especially encouraged by our CFAR, to bring about the fruitful juxtaposition of techniques, ideas, and concepts from different labs and disciplines. The Specific Aims for the Developmental Core are: 1. To provide a mechanism for rapid review and concise application of high-quality, innovative research projects. 2. To develop RFAs for seed funding of promising projects in important and timely areas of AIDS research. 3. To develop RFAs to support and mentor investigators at the level of graduate, post-graduate, transitional, and new faculty?and, as necessary, to retain existing faculty. 4. To develop a mechanism for creating venues that encourage and facilitate close collaboration and novel approaches to AIDS research. These venues include, but are not limited to, think tanks, conferences, and seminars. 5. To mentor and prepare seed grant applicants in the process of preparing successful grant applications. 6. To supplement the activities of the above four aims through private-fund raising efforts. This aim is coordinated in part by the Administrative core, in collaboration with the UCLA AIDS Institute. No support is requested here.

Public health relevance
RELEVANCE (See instructions): The Developmental Core aims to promote research in ways that cannot be easily supported by individual research grants; i.e. providing modest grants to young/new investigators through a competitive review process, by mentoring these investigators at a critical time in their careers and by supporting collaborative research efforts of all Faculty through symposia, think tanks and community outreach events.